Project 04: Molecular Carcinogenesis and Chemoprevention (MCC)

PROJECT SUMMARY – MOLECULAR CARCINOGENESIS AND CHEMOPREVENTION (MCC)
The Molecular Carcinogenesis and Chemoprevention (MCC) Program at The Ohio State University
Comprehensive Cancer Center (OSUCCC), led by Steven Clinton, MD, PhD, and Richard Fishel, PhD, has
48 members from 22 Departments and 8 OSU Colleges (Arts and Sciences, Dentistry, Education and Human
Ecology, Food, Agriculture and Environmental Science, Medicine, Pharmacy, Public Health, and Veterinary
Medicine). The MCC Program examines cancer as an integrated and dynamic process over time, with a major
focus on the interface between genetics and the environment that collectively impacts the carcinogenesis
cascade. This approach provides a foundation for chemoprevention and dietary interventions to reduce the
burden of cancer in high-risk individuals as well as to decrease the incidence, mortality and morbidity of cancer in
our Ohio catchment area (CA) and the nation. Our expertise extends to defining standards for genetic screening and
counselling as well defining dietary and nutritional guidelines that impact cancer risk through public policy, nationally
and globally. The Specific Aims of the MCC Program are: 1) Carcinogenesis: To characterize the genetic,
molecular and cellular changes induced by germline, chemical, physical, hormonal or microbiological mediators
that contribute to neoplastic transformation and multistage carcinogenesis; 2) Chemoprevention: To develop and
characterize novel cancer chemopreventive agents and define their efficacy, safety, and mechanisms of action
using biochemical, cellular and preclinical models that ultimately lead to early phase human studies; and, 3) Diet,
Nutrition and Metabolism: To identify dietary patterns, nutritional components, and lifestyle variables that
enhance or inhibit the carcinogenesis cascade across the continuum of cancer progression. MCC Program
members published 547 cancer-relevant manuscripts between 12/01/14 and 11/30/19. Of these, 14% were intra-
programmatic (multiple authors from MCC Program), 31% were inter-programmatic (authors from multiple OSUCCC
Programs), and 72% were multi-institutional (authors from both CC and another institution). The total collaborative
publications is 83%. MCC Program funding stands at $7.9M in overall direct, cancer-focused funding, of which
$7.0M is peer-reviewed, including $6.8M direct funding from NIH ($3.4M from NCI). Over the last five years, MCC
Program members have accrued 1,487 participants to trials; 670 to interventional trials and 817 to non-interventional
trials. MCC members serve as leaders of the Ohio Colorectal Cancer Prevention Initiative involving 3,651
participants (3,310 colorectal and 341 endometrial) and ORIEN Total Cancer Care with enrollment of 50,683.The
MCC program is fully integrated with the high priority crosscutting research initiatives of the OSUCCC and future plans
complement and enhance programmatic aims while promoting interactions with the other research Programs and focus
on 1) metabolic signatures in carcinogenesis and prevention; 2) the microbiome and immunology interface with
Pelotonia Institute for Immuno-Oncology initiatives; and 3) collaborative efforts with the Center for Cancer Engineering.